Multidisciplinary Research Training to Reduce Inequalities in Cardiovascular Health

This is an application for the first five-year renewal (years 6-10) of the Multidisciplinary Research Training to Reduce Inequalities in Cardiovascular Health (METRIC) T32 for predoctoral and postdoctoral fellows at Emory University. The goal of the METRIC T32 program is to train outstanding candidates in the study of cardiovascular health inequalities broadly defined, based on factors such as race/ethnicity, sex, socioeconomic status, geographical residence, healthcare access, and physical/mental disability, with a focus on the underlying biological, behavioral and environmental mechanisms. A distinguishing feature of our program is the utilization of a multidisciplinary approach to expose trainees to multiple methods and research areas, from epidemiology and biostatistics to behavioral and social sciences, biological sciences, and health policy and implementation. Each trainee has a primary mentor but works within a mentoring team with multidisciplinary expertise. A maximum of 5 predoctoral and 5 postdoctoral trainees will be in the program at any time point, each supported for an average of 3 years for predocs and 2 years for postdocs. Training will include multidisciplinary mentoring along with coursework, inter-departmental seminars, hands-on research, grant writing and career development. Our main source of predoctoral applicants will continue to be PhD students entering the School of Public Health's doctoral programs. Postdoctoral fellows will be MDs pursuing a research career in cardiovascular disease, or PhD graduates in epidemiology, nutrition, behavioral sciences, environmental sciences, health policy, or other relevant areas. Postdoctoral trainees will have the opportunity to obtain a MS in Clinical Research. In the past funding cycle all our training slots were filled. The program shows a strong track record for successful training and career development, promoted by solid collaborations among the Rollins School of Public Health, the School of Medicine, the School of Nursing, and the Morehouse School of Medicine. Our program responds to several emphasis areas for NHLBI T32 programs, including multidisciplinary training, collaborative research, quantitative sciences, and translation research, with strong emphasis on mentorship and career development. Addressing cardiovascular health inequalities is a top priority of the strategic vision of the NHLBI's Division of Cardiovascular Sciences. The ultimate goal of this program is to prepare outstanding individuals for leadership positions in biomedical and health care research in order to build capacity for research and translation to reduce inequalities in health and health care for cardiovascular disease.

Public health relevance
Project Narrative Inequalities in cardiovascular health are a pervasive problem that has remained essentially unchanged over the past several decades in the United States. This T32 competing continuation application proposes to train the next generation of leading researchers to pioneer innovative research using a multidisciplinary approach in order to reduce cardiovascular health disparities.